EFFECTS OF SWIM AND RESISTANCE TRAINING ON MUSCLE PROTEIN METABOLISM

Resistance training is an integral part of training for competitive swimming. It is not certain that resistance training provides beneficial adaptations of the muscles over & above that achieved from swimming training alone. Increase in muscular strength is an important adaptation to swim-training. Increases in net protein synthesis are necessary for muscle hypertrophy & strength increases in muscles. We will determine training on protein anabolism in deltoid muscles of swimmers, measuring muscle protein synthesis, using stable isotope tracer methods.